Reelin and Fragile X Syndrome

This grant initiative undertakes an exploration of Reelin, an extracellular signaling protein, and its role in
Fragile X syndrome (FXS). FXS is the most prevalent inherited form of intellectual disability, that manifests with
a spectrum of clinical symptoms including impaired cognition, anxiety, hyperactivity, social phobia, and repetitive
behaviors. FXS has an estimated prevalence of 1 in 7,000 males and 1 in 11,000 females (Centers for Disease
Control). The core pathology of FXS stems from loss-of-function mutations in the X-chromosome gene FMR1,
resulting in a lack of FMRP (Fragile X Messenger Ribonucleoprotein Protein) expression. FXS remains an
enigmatic challenge, devoid of a cure, with available medications merely aimed at mitigating specific symptoms,
such as anxiety, hyperactivity, aggression, and attention deficits.
As a single-gene disorder, FXS stands out as a promising candidate for viral-vector-based gene therapy,
however, the Fmr1 gene therapy approach has not resulted in the amelioration of phenotypical behaviors as
anticipated. Many studies failed to report cognitive tasks or show cognitive recovery despite successful FMRP
expression. Considering that the loss of FMRP function results in the disturbance of typical synaptic signaling,
the goal of restoring synaptic function emerges as a compelling alternative therapeutic avenue for FXS—a terrain
yet uncharted. Reelin offers a potential therapeutic target as it has emerged as a pivotal player in orchestrating
synaptic dynamics. Our lab’s focus on neurodevelopmental disorders led us to identify 50% reduction in Reelin
in the FXS mouse model. The tantalizing prospect that a decline in Reelin might underpin the synaptic
dysregulation in FXS, we hypothesized that restoring Reelin signaling would improve synaptic signaling in FXS.
Subsequently, we published that Reelin supplementation was able to fully rescue cognitive deficits in the
FXS mouse model. As a follow up, we now demonstrate that an optimized minimal active Reelin fragment can
also completely rescue cognitive deficits in the FXS mouse. More importantly, this construct can be expressed
using a gene therapy approach, to amazingly completely restore the cognitive deficits in the FXS mouse model
back to wild-type performance levels.
In this proposal we further validate this gene therapy approach in Aim 1 with examination of new viral
vectors that offers a less invasive gene delivery for the brain. We hypothesize that this will be as efficacious as
our preliminary data, and could enhance the translatability towards a human therapeutic. In Aim 2 we will
endeavor to determine the mechanism of action of Reelin in FXS. Currently there is no known direct interaction
between Reelin and FMRP, but we hypothesize that Reelin indirectly rescues FMRP loss through the regulation
of the synaptic proteins such as STEP and PSD-95. We will take an unbiased approach to examine the
mechanism of increased Reelin signaling in Fmr1 KO mice using RNAseq and biochemical analysis of treated
versus control mice.

Public health relevance
PROJECT NARRATIVE Fragile X syndrome (FXS) is the leading genetic cause of inherited intellectual disability, which is characterized by autistic behaviors, childhood seizures, and abnormal dendritic spines and as yet there are no known treatments for FXS. There is currently no therapeutics for the treatment of this disease. We propose to validate a novel gene therapy approach for the treatment of FXS using a novel gene therapy construct expressing a Reelin protein fragment and explore to the mechanism of Reelin action in FXS.